Mechanical Regulation of Cell Fate and Multi-Scale Function in the Developing Meniscus

Abstract
The meniscus plays a vital role in healthy knee function. However, given the centrality of this tissue in load
transfer and the demanding physical environment, injury is common and healing in adults is limited. The
current lack of regenerative solutions for knee meniscus injury arises, in part, from the significant gap in our
understanding of the cellular origins and regulation of meniscus tissue during development. While it is well
appreciated that the meniscus arises from a specialized progenitor cell population that first defines the forming
synovial joint (interzone cells), the regulation and timing of the differentiation of these cells, their phenotypic
heterogeneity, the type and timing of matrix that these cells produce within defined intervals, how this matrix
matures and feeds back to influence cell function and fate, and the role of active mechanical forces (that begin
during the first stages of joint motion), remain poorly understood. To address these limitations, this proposal
uses a series of novel mouse models and micro-scale experimental techniques to investigate the origin and
track the fate and function of cells that comprise the mature meniscus. We will also define the time-evolving
structural and mechanical features of the developing matrix, and query the role of joint loading and cellular
response to mechanical inputs in this developmental paradigm. Our central hypothesis is that a common pool
of meniscal progenitor cells arises from the interzone, that these cells are acted on by microenvironmental
cues defined by early matrix assembly and active mechanical signals (that arise with joint loading), and that
these inputs act together to refine and direct meniscus maturation, enabling its adult function.

Public health relevance
Narrative The meniscus plays a vital role in healthy knee function, but the cellular origin and developmental and post- natal regulation of meniscus tissue formation and maturation remains poorly understood. This proposal seeks to fill this knowledge gap using a series of novel mouse models and micro-scale experimental techniques to track the fate and function of cells that comprise the mature meniscus, define the time-evolving mechanical features of the extracellular matrix microenvironment, and determine the role of joint loading in this developmental paradigm.